MEMORI Corps: A novel activity-based companion care program to benefit community-living persons with dementia, their families, and senior volunteers

PROJECT SUMMARY/ABSTRACT
Dementia is a high cost, high burden public health challenge. These include needs for respite and relief for the
family, behavior management, supervision, and meaningful activities for the person with dementia (PWD).
Family caregivers (CG) provide most of the care required, yet demographic trends project a steep decline in
the availability of such CGs—signaling a looming crisis. A changing CG demographic (e.g. younger
caregivers, caring for multiple persons while working) will also contribute to shortages in availability. Previously
proven psychosocial and skill-building interventions are important care strategies to improve outcomes, but are
also time intensive for caregivers to learn and implement. Also, these interventions do not typically afford
family CGs with respite opportunities—a nearly universal need. Thus, new approaches to supporting families
living with dementia are urgently needed.
This is a randomized controlled trial (NIH Stage III) to evaluate the feasibility and efficacy of Making
Engagement Meaningful through Organized Routine Interaction (MEMORI) Corps, a novel activity-based
companion care model delivered in the home to community-living persons with dementia (PWD) and their
family caregivers (CG) by trained and supervised senior volunteers vs. Augmented Waitlist Control. The goal
of the program is to address unmet respite care needs for dementia family caregivers, provide persons with
dementia meaningful evidence-based activity programming, as well as provide health benefits, meaningful
productive engagement, and peer support opportunities for senior volunteers. Core intervention components
are derived and synthesized from Tailored Activities Program® , Experience Corps® and MIND at Home®
and include: (1) detailed initial home-based assessment of interests and preserved abilities of PWD; (2)
individualized activity program plans based on interests and abilities; (3) training of volunteers in
communication and simplification strategies and use of activity program plans; (4) delivery of activity plans by
volunteers to PWD over 12 weeks (8 hours/week) in their homes; (5) family caregiver education on activity
plans and ways to utilize respite opportunities; and (6) support of volunteers from a skilled multidisciplinary
clinical team. PWD/CG outcomes will be assessed at BL, 6-, and 12-weeks (PWD/CG participation lasts 12
weeks). Volunteer outcomes will be assessed at 6- and 12-months (Volunteer participation lasts 12 months).
This model program could serve as an important new advancement for community-based long term care for
PWD that addresses unmet patient- and family-centered needs through civic engagement of seniors.

Public health relevance
PROJECT NARRATIVE This is a randomized controlled (NIH Stage III) trial to evaluate the efficacy and feasibility of the MEMORI Corps program, a novel activity-based companion care program delivered in the home by trained and supervised senior volunteers. The goal of the program is to address unmet respite care needs for dementia family caregivers, provide persons with dementia meaningful evidence-based activity programming, as well as provide health benefits, meaningful productive engagement, and peer support opportunities for senior volunteers. If successful, this model program could serve as a new and important service to advance community-based long term care support for dementia patients and address unmet patient- and family- centered needs through civic engagement of seniors.